Neurotrophic Drug Development for Alzheimer's Disease

Drug development for the cognitive deficits in Alzheimer’s Disease has proven to be challenging.
Although major progress has been made in understanding disease pathophysiology and removal of
pathogenic agents, it has not resulted in substantial cognitive improvement. Failures of clinical trials and
strong side effects of approved drugs has made it necessary to explore alternate approaches. We
propose a neurotrophic therapeutic approach to address the debilitating cognitive dysfunction in AD.
Erythropoietin (EPO), which is widely prescribed for the treatment of anemia, has been shown to exhibit
robust neurotrophic activity in the brain. It is understood that these neurotrophic effects are centrally
involved in its ability to improve cognitive function. Multiple clinical trials in psychiatric disorders have
reported significant improvement in cognitive function after EPO treatment. However, EPO has potent
erythropoietic activity that can result in adverse hematological consequences with chronic
administration. To overcome this key limitation, we have produced a triple substitution, recombinant
neurotrophic molecule that is non-erythropoietic but retains the neurotrophic and cognitive effects of
EPO. The goal of this proposal is to perform Phase I feasibility studies to advance our invention. The
aims are designed to test bioreactor scaleup of protein production, determine toxicity and demonstrate
functional efficacy in AD model mice. The results of the Phase I studies can provide a new direction
towards commercial development of a neurotrophic action based therapeutic molecule.

Public health relevance
Neurotrophic factor molecules are centrally involved in regulating cognitive function by virtue of their neuronal actions in the brain. The proposed studies will test the feasibility of developing a recombinant neurotrophic factor as a cognitive drug for Alzheimer’s Disease. These studies can lead to the commercial development of trophic factor therapeutics to treat cognitive disorders.